Protein homeostasis in a frontotemporal dementia iPSC model

Maintaining protein homeostasis is a particular challenge for neurons, in which a high demand for protein
synthesis, folding and transport represents a constant source of stress. Evidence of protein mishandling is
observed in nearly all neurodegenerative diseases including the AD-related dementias (ADRD). The AAA-
ATPase valosin-containing protein (VCP) plays a central role in maintaining multiple aspects of protein
homeostasis. Mutations in VCP have been linked to several forms of frontotemporal lobar degeneration with
or without concurrent motor dysfunction and musculoskeletal disease. Yet there is limited understanding of
how these mutations affect different aspects of VCP function in neurons. The VCP-T262A mutation causes
familial frontotemporal dementia with aphasia and parkinsonism. Preliminary studies in primary neurons
transfected with VCP-T262A reveal deficits in dendritic arborization, and patient fibroblasts bearing the
endogenous mutation exhibit disrupted secretory function. Reagents to create human neurons and other
relevant cell types bearing the endogenous VCP-T262A mutation are critically needed to study
pathophysiological mechanisms of disease. In this exploratory project, we will create isogenic pairs of iPSC
lines expressing T262A vs. wild type VCP. We will differentiate to cortical neurons to study the effects of this
mutation upon ER stress, autophagy and Golgi markers compared to iPSC-derived cells with a mutation in
a different VCP functional domain. Our long-range goals are to understand how alterations in VCP
contribute to synaptic loss so that this mechanistic understanding can be translated into new therapeutic
approaches.

Public health relevance
The valosin-containing protein (VCP) functions as a regulatory hub for multiple facets of protein homeostasis. Mutations in VCP cause familial neurodegeneration with features of frontotemporal dementia and musculoskeletal disease. We will create new pluripotent cellular models derived from patient fibroblasts to study which of the major VCP functions are altered by a disease-causing mutation in human brain cells.